Visualizing cell dormancy in a Her2 Crainbow model of breast cancer metastasis

Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-029. Dr. Snyder’s OMF R01, “Visualizing tumor heterogeneity in an immune intact and autochthonous mouse
model of breast cancer” has approximately two years remaining on the award. The objective of this parent award,
is to recapitulate the genetic heterogeneity of HER2 oncogenes in a genetically tractable model more closely
resembling the human condition – including an intact immune system and stromal network. Our approach has
been to validate a Cancer rainbow (Crainbow) mouse model of HER2+ breast cancer to visualize wildtype (WT),
the splice-isoform exon 16 null isoform (d16), and the N-terminally truncated null isoform (p95). The parent R01
award is broadly demonstrating heterogeneity of tumor cell states, immune responses, fibroblast cross-talk, and
the effects of HER2-targeted therapy. New preliminary data show that HER2 Crainbow isoforms differ in their
metastatic potential and their primary tumor cell lines are also associated with distinct dormancy states including
expression of the dormancy marker, NR2F1. Additional, preliminary support shows that the HER2 Crainbow cell
lines differ in their intrinsic ability to evade the immune system. This collaborative supplement supports testing
the hypothesis that p95 cells express gene signatures characterized by NR2F1 dormancy and Nectin2 immune
checkpoint to promote metastatic potential and immune escape of dormant tumor cells. Two specific aims are
proposed that will in (Aim 1) Determine the role of NR2F1 overexpression in dormancy and dissemination of p95
HER2 expressing tumor cells and in (Aim 2) Determine a role for Nectin2/3 in promoting immune escape in
dormant p95 tumor cells. Dr. Bravo-Cordero’s expertise is necessary for the proposed intravital imaging studies
and his expertise in tumor dormancy signaling. Already, our team has initial studies and established Crainbow
cell lines and Crainbow mouse models at Dr. Bravo-Cordero’s laboratory. Therefore, the proposed supplement
is already “shovel-ready” and has a high likelihood of success. The expected outcome of this supplement is
three-fold: i) The supplement will continue to validate the HER2 Crainbow modeling technology as an important
tool for visualizing tumor heterogeneity in immune intact models. ii) The supplement will also provide necessary
resources for continuing to foster an early collaborative relationship between Drs. Snyder and Bravo-Cordero by
providing time and funds to complete a manuscript and then apply for subsequent collaborative project grants.
iii). The supplement will also provide important funding for demonstrating a new molecular mechanism that
induces dormancy and promotes immune escape. Overall, this will provide an exciting strategy for promoting
immune recognition of dormant tumor cells and thereby preventing or treating metastatic cancers.

Public health relevance
Project Narrative This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA- 24-029. Although treatment of early-stage HER2+ breast cancers is curative, metastatic HER2+ breast cancer is incurable. This project is relevant to public health because it will demonstrate how HER2 isoforms activate dormancy programs and immune checkpoint to drive tumor dormancy and dissemination of cells that escape the immune system. Our work will provide a new possible strategy for activating the immune system and treating dormant and metastatic tumor cells.